LIMA: Lipid anti-Inflammatory Mediators in Asthma to reduce airway hyperresponsiveness in obese asthmatics

Abstract. Obesity induces a chronic systemic inflammatory state characterized by impaired adipokine signaling,
increased pro-inflammatory cytokine expression, inflammatory cell activation, enhanced generation of oxidizing
species and pathogenic shifts in metabolic intermediates and microbial profiles. This impacts pulmonary function
and increases the incidence of asthma and its exacerbations that are resistant to conventional asthma therapies.
Unsaturated fatty acid nitration products (NO2-FA), generated by metabolic and inflammatory reactions, can
orchestrate diverse adaptive signaling responses. When administered as pure synthetic homologs, NO2-FA
mediate post-translational protein modifications that modulate activities of multiple enzymes, receptors and
transcription factors regulating metabolism and inflammation. Oral administration of synthetic NO2-FA 10-nitro-
octadec-9-cis-enoic acid (termed NO2-OA or CXA-10) is a safe, novel pleiotropic drug candidate that is a
synthetic homolog of an endogenous mediator. In murine models of metabolic syndrome, obesity-associated
allergic airway disease and pulmonary inflammation affirms that CXA-10 induces anti-inflammatory responses
and normalizes airway function. We will evaluate the promising pharmacology of this new drug class via Phase
2 evaluation of the therapeutic effects of CXA-10 in subjects with late onset obesity-associated asthma. We will
a) define changes in pre bronchodilator FEV1, asthma control, and methacholine responsiveness following daily
oral CXA-10 administration to obese subjects (BMI >30) having airway hyperreactivity, via a blinded, placebo-
controlled, double cross-over study design and b) evaluate the impact of CXA-10 administration on study subject
nasal and pulmonary airway cell gene expression, urine, plasma and bronchoalveolar lavage inflammatory
biomarkers and gut-lung axis microbiome responses. These mechanistic studies will reveal how CXA-10 directs
the electrophilic NO2-FA-sensitive genome and microbiome to modulate systemic and airway metabolic and
inflammatory intermediates that contribute to the obese asthmatic phenotype. We hypothesize that nitro-fatty
acid-induced signaling and metabolic responses will improve lung function, asthma control and alleviate
obesity-related airway hyperreactivity. To test this hypothesis, Aim #1 evaluates the clinical responses of
obesity-associated asthma patients to the orally-administered nitro-fatty acid, CXA-10 and Aim #2
identifies the downstream host and microbial gene expression and metabolic responses of subjects
before and after oral CXA-10 administration. Current data encourages that, in the setting of obesity, CXA-10
will limit lung dysfunction, promote adaptive signaling responses and shift gut bacterial populations and metabolic
intermediates so as to beneficially impact the gut-lung axis.

Public health relevance
PROJECT NARRATIVE The research plan is designed to test the beneficial metabolic and anti-inflammatory actions of an endogenously present class of modified fats, termed nitro-fatty acids. This project provides a novel precision pharmacology therapy, oral CXA-10, for the treatment of obese asthma, a disease that responds poorly to standard asthma medications and increases airway hyperreactivity. The study will leverage both clinical variables (lung function, asthma control questionnaire and bronchial hyperreactivity) as well as the use of gut, lung, nasal, plasma and urine samples as a translational research tool to better understand obesity-mediated changes in relation to how CXA-10 effects changes in gene expression and how –omics profiles are modified by CXA-10.